Institute for Translational Research Education (ITRE) in Adolescent Substance Use

Abstract
The applicant proposes the continued development and expansion of a successful research
education program for graduate level students and professionals to acquire innovative research
skills to address drug abuse and related behavioral health concerns of children and adolescents
with an emphasis in implementation science. We continue our effort of addressing research
education that target minorities and under-represented groups of researchers with interests in
working with high risk populations including children and families of AI descent and Hispanic
populations with substance abuse and other co-morbid behavioral health conditions. We
continue to innovate through the utilization of Peer Mentors who are provided advanced
research education opportunities in research project leadership. Implementation Science
continues to be at the forefront of innovative research education; the Institute for Translational
Research and Education in Adolescent Drug Abuse (ITRE) is unique in focusing on training in
implementation research methods, with practical applications in programs at the community
level. We emphasize translation of implementation research into community practice and the
practical skills of participatory research. A cross-disciplinary approach, involving multiple
colleges at the University of South Florida and Northern Arizona University, as well as local
community service agencies, has been developed with special attention to evidence-based
practice, translational research, and children and adolescents from high risk, marginalized
populations.

Public health relevance
Project Narrative This project proposes the continued development and expansion of an innovative model of research education that addresses best practices for translational research in the field of child and adolescent behavioral health, as it relates to substance abuse and co-occurring disorders with an emphasis on at-risk populations including children and families of AI descent and Hispanic populations.